Structural Analysis of SERPINA1 RNA in A1AT Deficiency

ABSTRACT Alpha-1 antitrypsin (A1AT) deficiency is one of the most common monogenic diseases in North America and can lead to emphysema and severe liver disease. Hundreds of disease-associated mutations are known, resulting in insufficient levels of A1AT in the lungs and pathological aggregation in the liver. A1AT deficiency results in excessive lung remodeling due to excess local protease activity, while intracellular aggregation leads to liver destruction. The gene that encodes A1AT, SERPINA1, expresses a large number of mRNA isoforms, all generated by alternative splicing in the 5?-untranslated region (5?-UTR). Although all SERPINA1 mRNAs encode exactly the same protein, expression level of the A1AT protein varies substantially from the overall RNA transcript level in different human tissues, suggesting there is significant post-transcriptional gene regulation. Prior work proposes that distinct structures in the 5'-UTRs of SERPINA1 enhance or disrupt ribosomal translation. However, structural models of these motifs have not been developed based on in-cell analyses and the extent to which these structures regulate endogenous protein translation is relatively unexplored. Thus, understanding expression of A1AT represents a unique opportunity to define RNA-mediated regulation of lung disease and, in the long term, develop new classes of RNA-targeted therapeutics. Through this training proposal, I propose to identify and characterize higher order RNA structures in the 5'-UTR of SERPINA1 mRNA at single-nucleotide resolution in cells and across different cell types using modern high- throughput chemical probing methods. The functional importance of newly discovered RNA regulatory structures will be examined using a high-throughput structural-mutational screen and follow-up functional analyses. This research will provide training in cell biology, novel chemical RNA structure probing methods, next-generation sequencing strategies, and computational tools for bioinformatics analyses. I will also participate in mentored clinical activities focusing on the care of patients with genetic lung diseases. This project will result in a deep understanding of the role of 5'-UTR structure on gene expression, on the influence of different cellular environments on RNA structure-mediated gene expression, and on the interplay of mechanistic studies and opportunities for long-term clinical intervention. These findings will explore RNA as a drug target and define new potential targets for the treatment of A1AT deficiency. The proposed multidisciplinary training will integrate my clinical and research interests and prepare me to become a leading physician-scientist in RNA structural biology.

Public health relevance
PROJECT NARRATIVE Severe liver disease and emphysema are both direct consequences of alpha-1 antitrypsin deficiency, one of the most common monogenic diseases worldwide. We propose to characterize the structural consequences of mutations in the 5'-UTR of the SERPINA-1 mRNA that either increase or decrease protein translation and to engage in mentored clinical care of patients with lung-related genetic disease. Over the longer term, this project and training program will inform strategies for small molecule interventions with end-goals to either increase protein translation of functional SERPINA-1 in the lung to prevent emphysema and/or decrease translation in liver to prevent cirrhosis in alpha-1 antitrypsin deficiency.